Core A: Administrative Core

PROJECT SUMMARY – CORE A
In this competing renewal P01 application, the Administrative Core (Core A) will provide 1) a structure to
facilitate effective interactions toward accomplishment of the aims of this Program Project and specifically will
foster and promote the goals of the Program and each component (cores and projects) by providing scientific
direction, administrative support, oversight, and integration of P01 activities ensuring operational efficiency for
the Program. The Specific Aims of the Core A are:
Aim 1: Provide research direction by setting the research agenda to utilize the HTLV-1 T-cell immortalization
model to gain understanding of the microenvironmental, cellular, and viral factors that lead to progression to
leukemia, and with this knowledge, to identify unique targets for diagnosis and treatment of HTLV-1 infection
and adult T-cell leukemia and related leukemia/lymphoma.
Aim 2: Ensure operational efficiency for Program components by providing centralized grant administration,
information dissemination, budget data processing, scientific data and resource sharing, and exchange of
information and services.
Aim 3: Promote integration of the three Research Projects and the two Cores to advance interaction among the
investigators and between the two PPG institutions. Core A will also assist the cores and projects in staff and
faculty education and career development.

Public health relevance
PROJECT NARRATIVE – CORE A The Administrative Core (Core A) will provide a structure to facilitate effective interactions toward accomplishment of the aims of this Program Project. It will ensure that all components of the Program work seamlessly together to accomplish the Overall and specific project goals of the P01 Program.